Deuterium Labeling Mass Spectrometry for Rapid Antimicrobial Susceptibility Testing

PROJECT SUMMARY
Antimicrobial resistance (AMR) is a significant challenge for human health, especially with the emergence of
multi-drug resistance bacteria and the lack of new antibiotics development. In the United States alone there are
over 2.8 million cases each year with over 35,000 deaths. Worldwide annual deaths are over 700,000 and this
number is expected to grow to 10 million by 2050. There is a great concern that the COVID pandemic may have
increased AMR risk. While the next generation ASTs have been actively under development in the last decade
and some automatic tools were approved by the FDA, they are mostly based on morphological changes with
limitations in sensitivity and selectivity, mostly requiring overnight cultures and long turn-around-time.
Additionally, a separate capital investment is necessary for automatic AST instruments.
In vivo isotope labeling with heavy water (D2O) has been used to monitor microscale cellular responses such as
protein synthesis and turnover, DNA replication, and de novo lipogenesis. When bacteria are cultured in D2O,
newly synthesized bacterial lipids are labeled by deuterium and can be readily detected by mass spectrometry
(MS). We are developing a new antibiotic susceptibility test (AST) using deuterium-labeling mass spectrometry
(DLMS), in which AMR bacteria can be rapidly detected by a bench top matrix-assisted laser desorption
ionization time-of-flight mass spectrometer (MALDI-TOF) that is commonly available in many clinical labs for
bacterial species identification. Based on previous success on resistant E. coli and methicillin-resistant
Staphylococcus aureus (MRSA), our DLMS AST will be now applied to all ESKAPE (Enterococcus,
Staphylococcus, Klebsiella, Acinetobacter, Pseudomonas, and Enterobacter) pathogens using a bench top
MALDI-TOF, the Bruker Biotyper. The minimum inhibitory concentration (MIC) measured by DLMS will be
compared with a traditional broth dilution method, which is expected to be comparable but achieved in only a
few hours instead of one or two days. To further accelerate the adoption of this DLMS AST assay by clinical
bacteriologists, an on-agar assay will also be developed using ETESTÒ and D2O agar. Furthermore, we will
explore the discovery of new AMR metabolite biomarkers using DLMS, which will not only shorten the turn-
around-time but also provide information about resistant mechanisms. Our long-term vision is to have both global
markers (deuterated lipids) and specific AMR biomarkers (deuterated small metabolites) simultaneously
detected by DLMS using a bench-top MALDI-TOF, allowing prompt prescription of the most appropriate
antibiotics and reducing antibiotic overuse.

Public health relevance
PROJECT NARRATIVE Antimicrobial resistance has become a global threat to public health with annual deaths expected to grow above 10 million by 2050. The proposed research will develop a rapid antibiotics susceptibility test using a MALDI-TOF instrument commonly available in clinical labs. By incubating bacteria with heavy water (D2O) and antibiotics, its resistance can be measured with a minimal turn-around-time, allowing prompt prescription of the most appropriate antibiotics and reducing overuse.